PCORE (Partnership Community Outreach, Research, and Education Core)

One in three U.S. residents, over 100 million people, are minorities. Over 39 million are foreign-born. New York
City (NYC) is home to 3 million foreign-born. Among foreign-born New Yorkers, 48.8% are limited English
proficient (LEP), 27.8% did not graduate from high school, and 19.8% are living in poverty. This large and
diverse population faces significant disparities in cancer incidence, diagnosis, treatment, and outcomes. These
disparities are fueled by health information and systems access barriers, and by an inadequate evidence-base,
which stems from insufficient representation in research and program implementation. These factors limit the
bi-directional translation of discoveries between bench, patient, community, and policy levels. Over the past 10
years, the PCORE (Partnership Community Outreach-Research-Education) Core has implemented trailblazing
community-engaged outreach and research, and addressed socioeconomic determinants of health and gaps in
cancer outcomes and quality of care for large underserved communities, including the CCNY community, the
Harlem community in which CCNY is embedded, and the broader NYC community. Through partnerships and
model program dissemination, PCORE has also extended its activities across the U.S., and is a vital member
of several NCI and American Cancer Society Committees addressing the inclusion of diverse populations in
research. Over the next 5 years, PCORE will further grow the robust community-academic U54 partnership
and infrastructure for community-engaged outreach and translational research. PCORE has the following two
Specific Aims: AIM 1. To build upon and strengthen PCORE's community-academic partnership assets to
further develop, implement, systematically disseminate and sustain effective community-engaged cancer
disparities reduction outreach, community and provider education, service, policy, and research activities to
address socioeconomic determinants (centering on health care access) of cancer outcomes and decrease
disparities in five priority areas (determined by community-engaged needs assessments and guided by the NCI
Blue Ribbon Panel): a) Clinical trials enrollment, including in precision medicine/precision prevention and
immunotherapy activities; b) Colorectal cancer screening, and treatment access and completion; c) HPV
prevention, and screening for HPV-associated cancers; d) Prostate cancer screening, treatment access and
completion; and e) Cancer risk factors including tobacco, obesity, diet, physical activity, and occupation. AIM 2.
To build the capacity of researchers and community members to engage the community in the conduct of
translational research to reduce cancer disparities, working in concert with the Linguistic and Cultural
Responsiveness Shared Resource Core: a) To facilitate community engagement to further enhance and
sustain community capacity building, utilizing the extensive network developed by PCORE; b) To support the
U54 Partnership Cores, working groups, and projects and to collaborate with the MSK P30 CCSG to engage
limited English proficient (LEP) and other diverse populations in their programs and studies.

Public health relevance
Project Narrative As per solicitation PAR-18-767 (U54): Project Narrative: Do not complete.